Defining the major signaling mechanism which controls spontaneous cardiomyocyte proliferation in the Neonatal Stage

Project Summary
Spontaneous cardiomyocyte (CM) regeneration has been demonstrated in embryonic and neonatal mammals;
however, adult CMs go into cell cycle arrest as their turnover has been reported as minimal in human hearts and
rodents. Several recent discoveries to induce CM proliferation in adult CMs, such as Cyclin A2, mir199, YAP-
5SA, or the combination of CDK1, CDK4, cyclin B1, and cyclin D1 (collectively known as 4F), have provided new
mechanistic insights of our understanding of the cell cycle block in adult CMs. However, a pertinent question is
what is the major signaling pathway that dictates CMs to spontaneously proliferate in fetal/neonatal stages and
be abolished in adulthood.
Our recently published temporal single-cell RNA-seq data from 60-day mature hiPS-CMs indicates the presence
of a unique subpopulation of primed starting CMs that respond to the 4F. One of the major characteristics of this
primed population is the expression of the transmembrane scavenger receptor; CD36. CD36 is a fatty acid
internalization receptor with recent indications of regulating several signaling pathways. Our single-cell RNAseq
from primary CMs isolated from P1 hearts demonstrated that CD36 is expressed only in the spontaneously
proliferating CMs population and the responders to the 4F cell cycle stimulation. Our preliminary data show that
loss of CD36 global and CM-specific knockouts are born with smaller hearts, which contain fewer CMs compared
to their WT littermates. Furthermore, compared to their WT littermates that completely regenerate the heart apex
following apical resection at P1, CD36KO showed minimal regeneration of the apex. Mechanistically, bulk RNAseq
data from the P1 CD36KO hearts showed significant downregulation in the expression of the cell cycle genes and
the retinoic acid (RA)-cell cycle induction signaling genes, such as FABP5, PPARd, and RXR that coordinately
play a critical role in cell decision between proliferation and growth. Spatial metabolomics analysis demonstrated
a decline in retinoic acid esters within the CD36CKO hearts, which indicates a deficiency in retinoic acid
internalization. To confirm the causality of this proposed mechanism, in vivo, crossing CD36KO with CM-specific
PPARd overexpression (PPARdCTG) only in CMs rescued the proliferation deficiency phenotype in CD36KO in the
P1 hearts. We hypothesize that CD36 modulates RA signaling through esterification and internalization of the
RA to bind to FABP5 to activate the PPARd/RXR transcriptional program, thereby regulating the decision of CMs
to progress through the cell cycle when needed. To test this hypothesis, we will address these aims:
Aim 1: To address the hypothesis that CD36 internalizes RA to bind to FABP5 to initiate the signaling
mechanism. Aim 2: To test the hypothesis that RA/FABP5 binding is the rate-limiting step in the proposed
pathway to activate the PPARd/RXR transcriptional activity. Aim 3: To test the hypothesis that
FABP5/PPARd overexpression is a therapeutic target for ischemic heart failure.

Public health relevance
Project Narrative The mechanisms that influence cardiomyocyte proliferation and repair are poorly understood. This project will assess how changes in vitamin A influence the propensity of cardiomyocytes to divide during developmental stages. In addition, it will shed light on how baby hearts can heal better than adult hearts.